Targeting Circadian and Cognitive Dysfunction in Bipolar Disorder with Modafinil

DESCRIPTION (provided by applicant): Despite advances in the treatment of bipolar disorder, most patients do not achieve complete inter-episode recovery and functional disability is common. During periods of relative remission, many patients continue to experience sleep disturbances, reduced daytime activity levels, and neurocognitive dysfunction. These persistent features of the illness represent critical treatment targets, as they do not adequately improve with standard mood stabilizing medications and they are strongly associated with functional disability and poor quality of life. Psychosocial therapies have focused on the importance of stabilizing sleep-wake cycles and daily routines such as mealtimes and regular social interactions, resulting in significant reductions in affective relapse. No study, to date, has attempted to stabilize circadian rhythms using a pharmacologic intervention in bipolar patients. Thus, the proposed 8-week, randomized, placebo-controlled pilot study will evaluate the safety and preliminarily assess the efficacy of the wake-promoting drug, modafinil (Provigil(R)), on sleep, daytime activity, and neurocognitive functioning in 48 euthymic bipolar patients. Modafinil is approved by the US Food and Drug Administration (FDA) for excessive daytime sleepiness associated with several sleep disorders (narcolepsy, sleep apnea, and shift-work disorder). In an off-label application, we will administer randomize in a 2:1 ratio to active modafinil (200mg/day) or placebo to 48 affectively stable patients with bipolar I disorder for 8 weeks. We will measure patients' subjective experience of sleep disruption and daytime wakefulness by questionnaires and daily diaries. In addition, we will focus on modafinil's potential to improve neurocognitive functioning, including attention, memory and higher order cognitive processes in patients with bipolar disorder, as it has previously been shown to enhance cognition in psychiatrically healthy individuals, patients with sleep disorders, and patients with schizophrenia. To measure cognitive functioning, we will deploy several paper-pencil and computerized tests before modafinil is administered and again at the end of the 8-week study. Finally, although not a primary focus of the current study, we will also investigate the effects of modafinil on low-grade depressive symptoms independent of sleep ratings, regularity of social rhythms, and patient-reported quality of life. We will closely monitor patiets for unforeseen changes in mood symptoms that are deemed to place them at risk for developing mania or depression and will discontinue the trial as deemed necessary. We expect that findings from this study will identify a novel approach for treating those persistent symptoms of bipolar disorder not adequately addressed with current mood stabilizing agents, potentially resulting in a more complete recovery and improvement in day-to-day functioning.

Public health relevance
PUBLIC HEALTH RELEVANCE: Converging evidence suggests that patients with bipolar disorder do not achieve complete inter-episode recovery, particularly with regard to circadian-related sleep and daytime activity levels and neurocognitive functioning. These persistent problems, despite remission of acute affective symptoms, contribute directly to functional disability, highlighting the need for interventions above and beyond the standard treatments to achieve a full inter-episode recovery. The current study aims to investigate th effects of a novel psychostimulant, modafinil, on these persistent circadian and cognitive abnormalities in affectively-stable bipolar outpatients using a placebo-controlled, adjunctive, 8 week trial design. __SpecificAimsTextDelimiter__ Specific Aims Changes in the sleep-wake cycle and other circadian rhythms represent core features of bipolar disorder (BPD), with sleep abnormalities reported in ~90% of patients during acute episodes. Even when euthymic, many BPD patients continue to demonstrate circadian disruptions, including diminished sleep efficiency and lower daytime activity levels (Plante, 2008). Moreover, unaffected offspring of BPD patients demonstrate sleep and activity abnormalities (Ankers, 2009), and variation within several circadian-related genes (e.g. CLOCK) has been associated with risk for BPD (Dallaspezia, 2009). These trait-like circadian disruptions are of particular clinical relevance as changes in sleep are highly predictive of impending affective instability (Plante, 2008) and BPD patients with poor sleep quality report diminished quality of life (Gruber, 2009). Psychosocial treatments that incorporate the regulation of sleep and activity in BPD have been successful in reducing recurrence, highlighting the importance of stabilizing circadian rhythms in BPD (Frank, 2005)~ however, to date, no pharmacological intervention using circadian measures as primary outcomes in BPD has been published. The exact nature of the circadian abnormality in BPD is unknown~ theories posit a potential uncoupling of the biological clock from external variables that entrain circadian rhythms (e.g. light) versus the desynchronization of the sleep-wake cycle such that it falls out of phase with other biological rhythms (Dallaspezia, 2009). Euthymic BPD patients are commonly characterized by an eveningness chronotype, such that their time-to- sleep preference is phase-shifted to a later than average hour, one that is not typically aligned with the 24-hour light-dark cycle (Plante, 2008~ Ahn, 2008). Potential consequences related to these persistent circadian abnormalities include significant reductions in daytime wakefulness and neurocognitive impairment. While sleep deprivation induced by single-trial phase-shifts only impairs cognition until sleep is recovered, chronic phase-shifts, such as those noted in BPD individuals, have been implicated in significant learning and memory deficits in animal models (Craig, 2008). Moreover, humans who are unable to synchronize normal sleep-wakefulness schedules with their own internal biological clocks are impaired on tasks of processing speed, working memory, and learning (Wright, 2006). Indeed, a majority of BPD patients demonstrate deficits in attention, memory, and executive functioning even when affectively stable (Goldberg & Burdick, 2008). Although several features of the illness potentially contribute to the persistent cognitive impairment noted during euthymic periods, the circadian-based deficits in sleep quality and daytime wakefulness are likely to exacerbate cognitive problems in BPD (Giglio, 2010), as has been shown in healthy controls, sleep disordered subjects, and other clinical conditions (Benca, 2009). Our preliminary data support this relationship in BPD. The possible influence of chronic circadian disruption on cognition in BPD is of critical importance because of a strong association between cognition during euthymia and functional disability (Sanchez-Moreno, 2009). When considering agents that may simultaneously normalize circadian abnormalities and enhance cognition, the wake-promoting agent, modafinil, is an ideal candidate. It is FDA-approved for improving wakefulness in adults with excessive daytime sleepiness due to primary sleep disorders (Provigil®, 2007) and is characterized as a psychostimulant but has been differentiated from amphetamine by a lower liability for abuse and a more favorable risk profile. Modafinil has been shown to enhance cognition in healthy controls, sleep-disordered individuals, neurological patients, and schizophrenics (Minzenberg, 2008). Preliminary data indicate that modafinil is safe and effective as an adjunctive in depressed BPD patients, with no increased risk for mania- induction vs. placebo (Frye, 2007)~ however, there has not been a systematic trial in euthymic BPD patients with sleep and cognitive dysfunction as outcome measures. Thus, we will administer adjunctive, modafinil (200mg/day) vs placebo to 48 euthymic patients with BPD for 8 weeks with three specific aims: 1) To evaluate the safety of adjunctive modafinil in euthymic BPD. Adverse events will be carefully measured and recorded in an effort to determine the base rates for common side effects in BPD. Specifically, mood and psychosis ratings will be conducted weekly to address the potential for modafinil to exacerbate manic and/or psychotic symptoms. 2) To evaluate the effects of adjunctive modafinil in euthymic BPD on measures of sleep quality and daytime wakefulness. Patients' subjective experience of sleep disruption and daytime wakefulness will be measured weekly using standard questionnaires and daily diaries. 3) To evaluate the effects of adjunctive modafinil in euthymic BPD on measures of neurocognition. Cognitive functioning will be assayed using the MATRICS Consensus Cognitive Battery supplemented by several domain-specific tasks at baseline, 4-weeks, and at the end of the 8-week study. We expect that findings from this study will identify a novel approach for treating those persistent symptoms of bipolar disorder not adequately addressed with current mood stabilizing agents, potentially resulting in a more complete recovery and improvement in day-to-day functioning.